Pulmonary neuroimmune determinants of immunoglobulin production against pneumonia

Project Summary. Community acquired pneumonia cases are predominantly caused by infections from
Streptococcus pneumoniae. Evidence shows that effective adaptive immunity in the form of adequate antibody
production is necessary to protect against pulmonary S. pneumoniae infection. Emerging evidence demonstrates
that the sensory nervous system regulates innate and cellular immunity. Our data and others show that sensory
neurons are necessary for antibody production. Yet, the neuronal involvement in adaptive and humoral immunity
is under-investigated. Therefore, there is an urgent need to understand the neural regulation of humoral
immunity.
This application aims to investigate the role of sensory neurons in B cell maturation, immunoglobulin production
including class switch recombination, and interaction with neutrophils in response to pulmonary S. pneumoniae
infection. Our preliminary data have led us to hypothesize that in response to pulmonary S. pneumoniae infection,
sensory neurons release select neuropeptides to activate B cell immunoglobulin release, to interact with
neutrophils to clear infection. Secondly, we hypothesize that this downstream effect results from sensory neurons
being able to detect specific antigens. We show that 1) sensory neuron neuropeptide release is directly involved
in maturing and stimulating B cells in the lungs; 2) Sensory neuropeptides stimulate immunoglobulin production
in vitro and in vivo; 3) Sensory neurons appear to assist with B cell-neutrophil-interaction to assist with bacterial
clearance. With regards to neuronal antigen sensing, we show that 1) Sensory neurons harbor RNA required for
antigen sensing; 2) Antigen receptor proteins are upregulated in sensory neurons with repeat S. pneumoniae
exposure; 3) Sensory neuron stimulation with antigen increases neuronal excitation and select neuropeptide
release which has immunogenic properties and; 4) Neurons sequester immunoglobulins from B cells. We will
investigate this novel neuronal circuit of B cell immunoglobulin production and neutrophil interaction with two
aims. Studies in AIM 1 will investigate B cell development and maturation using flow cytometry, class-switch
recombination utilizing flow cytometry and tandem single-cell RNAseq and V(D)J repertoire analysis, and
neutrophil interaction using in vivo and in vitro assays, including single-cell RNAseq and flow cytometry. Studies
in AIM 2 will use electrophysiological recording, calcium imaging, and flow cytometry to assess a novel sensory
neuron antigen recognition signaling pathway and what this stimulation means regarding neuropeptide release.
Subsequent molecular assays will delineate the exact downstream effector molecule to identify potential drug
targets for future study. Finally, targeted antigen receptor deletion in sensory neurons with genetic models will
establish the necessity of neuronal antigen sensing to contribute to humoral immunity. Disease severity in all
aims will be assessed by enumeration of bacterial burden and immunoglobulin analysis. This contribution is
significant because it is expected to elucidate the role of sensory neurons in pulmonary adaptive immunity.

Public health relevance
Project Narrative The nervous system plays a prominent role in innate and cellular immunity in the lung by regulating immune cells in response to bacteria. However, our understanding of how sensory neurons sense bacteria and stimulate B cell immunoglobulin release in response to pulmonary infection to mediate humoral immunity is unclear. Thus, the proposed research is relevant to the NHLBI’s mission of developing fundamental knowledge to help reduce human disease burdens.